Phenotyping Net Immune State with MicroRNAs in Cardiac Transplantation

Currently, there are no reliable clinical strategies available to optimize immunosuppression levels after heart
transplantation. Patient survival after heart transplant is limited to 12 years and has not improved in the past two
decades largely attributed to the side effects of immunosuppression. Immunosuppression is used to prevent
heart transplant rejection, but the protective effects of immunosuppression are offset by multiple complications
including infection, chronic kidney disease, and cancer. There is no available biomarker available to assess the
alloimmune response after transplant and guide titration of immunosuppression. Thus, contemporary clinical
practice is to wean immunosuppression when drug toxicity arises or based on time after transplant. Through
circulating microRNAs, small non-coding RNA molecules, we will predict complications of over- (infection) and
under-immunosuppression (rejection). We hypothesize that circulating microRNAs can be used to quantify the
net immune state of heart transplant patients and identify patients at high risk for immunosuppression-related
complications. The scientific aims of this study will be accomplished through serial blood-based microRNA
sequencing and deep clinical phenotyping. We will build on our strong preliminary data to develop a panel of
microRNAs that predict these key post-transplant complications and correlate with varying doses or levels of
contemporary immunosuppression. This work will form the basis for a non-invasive, genomic blood test that can
be used to monitor patients after heart transplant to mitigate complications and enhance long-term survival.
The scientific aims of this proposal will be achieved through a prospective, multicenter, multiracial cohort study
of adult heart transplant patients (n=250) enrolled at 8 geographically- and socioeconomically diverse transplant
centers, with a high proportion of Black patients (target enrollment 30%) as these patients have worse clinical
outcomes after transplant. The specific aims of this proposal are: 1) identify circulating microRNAs that predict
the risk of major over- and under-immunosuppression related adverse events after heart transplantation, 2)
determine the response of the circulating microRNA transcriptome in heart transplant patients to changes in
immunosuppressive therapy, and 3) develop and validate a clinical microRNA score that provides a quantitative
assessment of the patient’s net immune state. This study will address several critical barriers needed to reduce
complications of immunosuppression, enhance patient quality of life, and improve long-term survival.
Development and validation of this microRNA biomarker panel in this study forms the basis for a new blood test
that can be used to manage transplant patients. This would allow clinicians to balance the risks of over- and
under-immunosuppression to personalize medications after heart transplant. The patient-specific assessment of
net immune state can then be evaluated in future randomized, controlled, clinical trials, where the microRNA
panel informs the titration of immunosuppression with the goal of mitigating the adverse event rate and enhancing
patient survival. This research also has important implications for other solid organ transplant populations.

Public health relevance
PROJECT NARRATIVE Median survival following heart transplant is only about 12 years and has not changed over the past two decades despite advances that have made transplant rejection less likely. Heart transplant patients must be treated with lifelong immunosuppressant medications to prevent rejection of the donor heart, but these medications make the patient vulnerable to infections, chronic kidney disease and cancer. This study seeks to determine if a class of molecules called microRNAs, which can be measured in the blood, personalize the dose of immunosuppressants each patient will need to prevent rejection of the donor heart while still minimizing the risk of infection.